Establishing a New Model of Bone Health in Formerly Premature Individuals

Abstract
This Exploratory/Developmental Research Grant will establish a new preclinical model of bone accrual
following preterm birth. The rationale is the presence of metabolic bone disease of prematurity that negatively
affects the skeletal health of preterm babies and the accumulating evidence of increased bone fragility in
former preterm babies entering later decades of life. While there are data for human subjects showing that
preterm birth is associated with skeletal deficiencies, successful intervention strategies that target the skeleton
are rare, partly because little is known about the underlying mechanisms. A barrier to the field is the lack of a
preclinical model in which bone tissue is directly interrogated and mechanistic studies are performed. We have
preliminary data of impaired postnatal bone development in a porcine model of prematurity in which we have
also identified heightened acetylation of histone 3 in cortical bone osteocytes. Based on these new findings, we
propose a novel scientific model system that has the high-risk, high-benefit merit to substantially advance the
field. We will test the hypothesis that premature birth in the pig model is associated with diminished bone
properties. Our analyses will focus on postnatal bone development through sexual maturity and the possibility
of improving early postnatal bone growth. In Aim 1, we assess bone mass, structure and composition by using
dual energy x-ray absorptiometry, microcomputed tomography, Raman spectroscopy and backscatter
scanning electron microscopy, bone function through mechanical testing to understand whole bone and
material properties and will determine if the model replicates the high levels of circulating alkaline phosphatase
and low levels of circulating phosphate that are the clinical signs most commonly monitored to diagnose
metabolic bone disease of prematurity. These studies will determine if the deficits we have seen up to
postnatal day 19 persist through the attainment of sexual maturity at 6 months. In Aim 2, we examine
proximate mechanisms (bone resorption and bone formation) and likely ultimate mechanisms (epigenetic
reprograming of gene expression and gut microbiome). In Aim 3, we determine if the resulting phenotype is
modifiable through use of a feeding formula based on egg yolk, leveraging an already funded study in which
the primary endpoint is neuro development. In future studies, we plan to use the model to examine age-related
bone loss, but believe it is logical to first evaluate the usefulness of the model to understand how preterm birth
affects postnatal skeletal development through early adolescence. Thus, we propose an innovative preclinical,
physiological model to study bone accrual following premature birth, its underlying mechanisms and possible
treatment. Identifying deficits in bone growth, modeling, remodeling, structure, density and strength in preterm
neonates would greatly facilitate the design, preclinical testing, and eventual implementation of interventions
that could improve life-long skeletal health.

Public health relevance
Narrative Individuals who were born preterm are at risk for bone fracture early in life and appear to be at higher risk for bone fractures later in life. This study will provide the first preclinical model to help determine the specific cause(s). A validated model is needed so that more targeted interventions can be developed to lessen the burden of disease.